Memory computations across hippocampal, entorhinal, and prefrontal circuits

PROJECT SUMMARY
A combination of entorhinal, hippocampal, and prefrontal pathology has a pivotal role in most neurological
and neurodegenerative diseases and in the emergence of memory impairments that are associated with these
diseases. Despite the knowledge that these brain regions are particularly vulnerable, the diversity of neural
computations within and across these brain regions is only beginning to be revealed. For example, a key
function of the hippocampus and medial entorhinal cortex (mEC) is to bridge events that are discontinuous in
time, and entorhinal and hippocampal cells that are sequentially active (‘time cells’) have been proposed to be
pivotal for memory retention over delay intervals of many seconds. In our previous work, we therefore
investigated the firing patterns over the delay interval in a spatial working memory (WM) task. We
unexpectedly found that hippocampal time cells were not a general mechanism for WM retention in
hippocampus-dependent tasks. Rather, preliminary data indicate that information about past and future
choices during the delay interval is evident during brief population bursts in hippocampus, while mEC cells
may show memory-related activity that persists irrespective of brain state. We therefore hypothesize that
memory retention does not require time-varying activity over the delay interval but is rather evident in
sporadic population bursts in hippocampus and medial prefrontal cortex (mPFC) throughout the delay period
and in firing patterns of entorhinal cells that provide continuity irrespective of brain state. To record activity
during the delay period with varying brain states, we will – within each animal – use two variants of a spatial
WM task, one with and one without forced running throughout the delay such that either theta or non-theta
states are predominant. Aim 1 will focus on population bursts in hippocampus and determine whether they are
only informative in non-theta states, as shown in our preliminary data, or a general mechanism across brain
states. In addition, we will selectively interrupt hippocampal activity within the delay period to determine
whether coding of future choices by population bursts and behavior are perturbed. Aim 2 will then perform
recordings across deep and superficial layers and along the dorso-ventral axis of entorhinal cortex to identify
how mEC contributes to WM. Finally, Aim 3 will carry out large-scale combined single-unit and LFP recordings
in hippocampus, mPFC and mEC to reveal the coordination of mechanisms for WM retention across brain
regions. In a research supplement, we will also investigate the coordination between mEC and dorsal striatum.
Taken together, we will identify whether neuronal activity during population bursts is a general mechanism for
memory retention irrespective of brain state, whether mEC supports WM retention with persistent activity, and
how subregions of mPFC are coordinated with hippocampal and entorhinal subareas along the dorso-ventral
axis. Identifying these memory computations will be the foundation for treatment approaches to restore
memory functions when brain circuits deteriorate in neurological and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE It is well established that the hippocampus, entorhinal cortex, prefrontal cortex, and/or basal ganglia as well as the coordination of activity across these brain regions are disrupted in any of the major neurological, neurodegenerative, and psychiatric diseases. Despite the knowledge that these circuits are particularly vulnerable in brain diseases, the diversity of memory computations that these brain regions support is only beginning to be revealed. By identifying how neural computations are performed and coordinated across brain regions, our results will be the foundation for therapies that profoundly improve cognitive function.